Defining the Role of PfCRT and PfMDR1 as Pleiotropic Mediators of Plasmodium falciparum Multidrug Resistance

PROJECT SUMMARY (See instructions):
Antimalarial drug resistance has repeatedly thwarted global efforts to treat and control malaria. Chloroquine,
the former gold-standard drug, earlier succumbed to parasite strains harboring mutations in the Plasmodium
falciparum chloroquine resistance transporter, PfCRT. Now, artemisinin-based combination therapies have
failed in Southeast Asia, driven in part by novel PfCRT variants that confer resistance to the first-line partner
drug piperaquine. Resistance to other partner drugs including amodiaquine, lumefantrine, and mefloquine can
be conferred by variant forms of PfCRT or the ABC transporter PfMDR1. Our R37 AI050234, funded since
2001, has substantially advanced research in this area including: publishing definitive evidence that PfCRT
mutations are the primary determinant of chloroquine and piperaquine resistance; attributing resistance to
PfCRT-mediated drug efflux; solving the PfCRT structure; defining fitness costs and physiological effects that
impact the spread of resistant alleles; globally mapping pfcrt and pfmdr1 variants across the globe; and
characterizing PfMDR 1-mediated multidrug resistance. Since our prior submission in August 2017 we have
published 23 articles including in Nature, Nature Microbiol, Lancet Infect Dis, and Cell Chem Biol. Our R37
MERIT Extension application proposes to advance this with four new Specific Aims. Aim 1: Define whether
mutant PfCRT can mediate piperaquine resistance in African strains. We will determine whether PfCRT
mutations that cause piperaquine resistance in Asian parasites will similarly confer resistance in African
strains with regionally distinct PfCRT isoforms. We will also assess the impact of these isoforms on other
antimalarials and on parasite fitness. Aim 2: Define genetic determinants that function epistatically with PfCRT
to mediate resistance. Using our recent P. falciparum genetic cross, we will positionally map and characterize
genes that are coinherited with mutant PfCRT in chloroquine- and/or quinine-resistant progeny and determine
whether these determinants augment resistance or have evolved to offset fitness costs. Aim 3:
Identify PfCRT-specific inhibitors that can reverse drug resistance. We propose to screen diverse chemical
libraries to identify compounds that block the efflux of chloroquine or piperaquine in drug-resistant parasite
lines. Assays with pfcrt-conditional knockdown parasites and recombinant PfCRT will test for compounds that
can bind this transporter, block efflux, and restore drug potency. Aim 4: Solve the PfMDR1 structure and
define its drug efflux properties compared with PfCRT. Following our recent success with PfCRT, we
propose to solve the PfMDR1 structure using cryo-electron microscopy. We will also perform binding and
transport assays with purified recombinant protein to characterize the resistance properties of PfMDR1
variants. This proposal, which aligns with the NIAID priority of supporting research on antimicrobial drug
resistance, will substantially advance our understanding of antimalarial resistance and yield biomarkers
and new strategies to counter drug-resistant malaria.

Public health relevance
RELEVANCE (See instructions): In this R37 Extension application, we propose to define the roles played by the Plasmodium falciparum transporters PfCRT and PfMDR1 in mediating parasite resistance to antimalarial drugs currently used in firstline combination therapies. Our studies will explore risks posed by PfCRT mutations in negating antimalarial drug efficacy in Africa, define genetic associations between PfCRT and other genes that augment resistance or offset parasite fitness costs, identify compounds that could reverse mutant PfCRT-mediated drug efflux, and characterize structural and functional features of PfMDR1-mediated drug resistance. Results from this project will advance our understanding of P. falciparum drug action and multidrug resistance , and offer evidence-based strategies to reduce the impact of drug-resistant malaria.